Immunosuppressive impact of the GPCR/MALT1 protease axis in triple-negative breast cancer

PROJECT SUMMARY/ABSTRACT
Breast cancer is the most common cancer in women. Triple-negative breast cancer (TNBC) lacks expression of
estrogen receptor (ER-), progesterone receptor (PR-) and human epidermal growth factor receptor 2 (HER2-),
the most common targetable markers in breast cancer. TNBC demonstrates the worst overall prognosis among
breast cancer subtypes due to lack of well-established targeted therapies. Because TNBC treatment relies
heavily on non-specific therapies, a significant need exists to identify innovative ways to harness the tumor
immune microenvironment to enable the effective use of immunotherapy.
I propose to investigate how the intracellular protein MALT1 promotes immunosuppression in the tumor immune
microenvironment (TIME) in TNBC. MALT1 is the effector protein of the CARMA-BCL10-MALT1 (CBM)
signalosome, a protein complex that is stimulated downstream of certain oncogenic G protein-coupled receptors
(GPCRs) and induces pro-survival NF-κB transcriptional activation. MALT1 acts via two main biologic functions:
(1) as a molecular scaffold and (2) as a protease. Our laboratory has demonstrated that in TNBC cells, MALT1
protease activity promotes tumor progression and metastasis by inducing epithelial-to-mesenchymal transition
(EMT). In many cancers, including TNBC, malignant cells undergoing EMT modulate the surrounding
microenvironment to polarize immune cells toward a cancer-promoting, immunosuppressive phenotype. Based
on my preliminary data, I hypothesize that MALT1 protease activity within TNBC cells promotes tumor immune
suppression through production of an immunosuppressive secretome.
In Aim 1 of this proposal, I will analyze MALT1 regulation of the TNBC TIME by characterizing MALT1 protease-
dependent secretion of immunosuppressive cytokines from TNBC cells. Experimental techniques utilized in this
aim will include CRISPR/Cas9 editing, mouse breast cancer models, tumor cell/immune cell co-culture, flow
cytometry, single cell RNA sequencing, and Olink® proteomics. In Aim 2 of this proposal, I will evaluate a novel
MALT1 protease activity gene signature for its clinicopathologic utility in predicting TIME status in TNBC.
Experimental techniques utilized in this aim will include use of patient-derived organoids, analysis of patient
tumor specimens, multiplex multispectral immunofluorescence, and a series of in silico analyses.
In summary, this project evaluates MALT1 protease as a potential driver of tumor progression via its effects on
the TNBC TIME. Completion of this proposal will provide me with rigorous research training by a remarkable
team of scientists and physician-scientists. This training experience will prepare me for a career as a physician-
scientist who develops new and innovative strategies for the treatment of patients with malignant solid tumors.

Public health relevance
PROJECT NARRATIVE Triple-negative breast cancer (TNBC) is a subtype of breast cancer that is associated with particularly poor outcomes and chemotherapy has been the mainstay of TNBC treatment for many years. With the recent advent of immunotherapy, certain patients with TNBC have experienced improved outcomes, although most patients fail to respond initially or develop resistance due to an immunosuppressive tumor microenvironment. This proposal investigates a molecular mechanism by which TNBC cells induce immunosuppression in their tumor microenvironment, paving the way for future development of new immunotherapeutic approaches to improving outcomes for patients with this challenging cancer.